Osteocytic mechanisms required for spatiotemporal control of bone quality

SUMMARY
Bone fragility cannot be explained by bone mineral density (BMD) alone and also results from defects in the
material properties of the bone matrix, termed bone quality (BQ). Since diagnostics or therapies to identify or
treat poor BQ do not exist, understanding the control of BQ is a clinical imperative for treating skeletal fragility.
This proposal aims to uncover these fundamental biological and material mechanisms controlling BQ by focusing
on the beneficial effects of exercise on BQ. Using a mouse exercise model that can reliably induce and rigorously
monitor dynamic changes in local BQ, Dr. Kohn found that exercise-dependent control of BQ strengthens bone
independently of BMD. Though the mechanisms responsible for the beneficial effects of exercise on BQ remain
unclear, compelling data suggest that exercise triggers osteocytic perilacunar/canalicular remodeling (PLR) to
exert spatiotemporal control of bone matrix structure and composition. The now well-defined model provides an
unparalleled opportunity to elucidate the cellular and molecular mechanisms by which BQ is controlled. Work
from the laboratory of Dr. Alliston implicates osteocytes in the control of bone matrix material properties through
the process of PLR. Several models of osteocyte dysfunction, including osteocyte-specific ablation of TGF-beta
signaling or SOD2, suppress PLR and result in compromised BQ. Preliminary data also show that osteocytic
PLR and cellular metabolism are coupled, suggesting that osteocytic mitochondrial function is tightly regulated
and plays a critical role in calibration of BQ to accommodate changing mechanical or metabolic demands.
However, the extent to which exercise exerts its effects on BQ through osteocyte or mitochondrial-dependent
mechanisms also remains unknown. It is therefore critical to define the sequence of cell and matrix changes
along the PLR continuum in an integrated mechanistic material-cellular approach. Using the well-established
models of regulating PLR and BQ via exercise or osteocyte-intrinsic genetic perturbations in TGF-beta and SOD2
signaling, and novel approaches to analyze BQ and PLR at the proteomic, compositional and structural levels,
we are in unique position to identify biological and material mechanisms by which exercise controls BQ. To this
end, we will test the hypothesis that exercise exerts spatiotemporal effects on BQ by modulating osteocyte
cellular metabolism and PLR by: Aim 1) identifying biological and material mechanisms by which exercise
controls BQ; Aim 2) identifying osteocyte-dependent mechanisms by which exercise regulates BQ; and Aim 3)
determining the extent to which BQ is regulated through mitochondria-dependent mechanisms. Results will
inform mechanisms by which BQ is controlled, in anticipation that these mechanisms may be diagnostic or
therapeutic candidates to intervene in people vulnerable to bone fragility because of low BQ.

Public health relevance
NARRATIVE One of the ways that osteocytes, cells embedded within bone, support skeletal health is by maintaining bone quality. An improved understanding of how osteocytes respond to stimuli, like exercise, to support bone quality will improve the success of clinical efforts to prevent bone fragility in aging or disease. Here we test the hypothesis that exercise directs changes in bone quality by modulating osteocyte cellular metabolism and remodeling of the matrix surrounding the osteocyte.